ANTIRETROVIRALS AND SPREAD OF HIV DRUG RESISTANCE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. These folks are at the Cleveland Clinic Foundation, and we are collaborators with them on a study of drug treatment and prevention strategies for AIDS in S. Africa. I am partially funded through their Gates award. We would like to use the filesystem on axon as a transfer location for large files. Later on in the year I will be running simulations for them on axon.